COLLABORATIONS AND PARTNERSHIPS CORE

The RMATRIX-II Collaborations & Partnerships Core will build and stengthen relationship among university- and community-based investigators, while developing new approaches to facilitate interdisciplinary research that addresses health disparities among Native Hawaiian and Other Pacific Peoples. Specifically, the Collaborations & Partnerships Core will support the overall Specific Aims of RMATRIX-II, which are to: (1) Foster clinical and translational health disparities research; (2) Build institutional and community research synergy; and (3) Advance the career development and mentoring of health disparities investigators. The Collaborations & Partnerships Core will advance these Specific Aims through the following activities. Specific Aim 1: a) Implement a redesigned Navigator Program that will provide a single point of entry and one-on-one guidance to facilitate, accelerate, and improve collaboration and partnership in clinical and translational research for university- and community-based investigators; b) Promote interdisciplinary health disparities research by implementing an RMATRIX-II Pilot Project Program that will allow biomedical investigators to generate preliminary data for submission of grant applications. Specific Aim 2: a) Link university-based and community-based investigators through the Navigator Program using personalized assistance and web-hosted guidance; b) Establish and develop an inter-institutional, multidisciplinary health services research group that will use pre-existing databases and other resources to examine health disparities among Native Hawaiian and Other Pacific Peoples. Specific Aim 3: a) Implement an integrated approach to career development and mentoring in collaboration with the Professional Development Core and Community-Based Research Core; b) Maximize the opportunities for career development and mentoring by encouraging Emerging investigators and Pilot Project Investigators to present their work to the appropriate RCMI Translational Research Network (RTRN) Cluster.

Public health relevance
The Collaborations & Partnerships Core will coordinate the development and strengthening of the multidisciplinary research relationships that are at the core of translational research and are a major strength of RMATRIX-II. Through its Navigator Program, Pilot Project Program, and other activies, the Core will support and coordinate the research needs of investigators examining health disparities in Hawaii.